Gene regulation of retinal cell differentiation

Abstract
Retinal progenitor cells possess remarkable multipotency since they can differentiate into all retinal neurons
and Muller glia in the retina. This multipotency is controlled by a sparse number of homeodomain and Sox
family transcription factors (TFs), such as Six3, Six6, Sox2, and Pax6. Mutations in these genes cause
human congenital eye abnormalities, such as microphthalmia, anophthalmia, and coloboma. Loss-of-
function studies in mice demonstrate that these multipotency TFs are essential for the competence of retinal
progenitor cells. Despite these advances, direct target genes of these multipotency TFs, mechanisms of
target regulation in chromatin, and molecular underpinnings of the multipotency remain elusive. To address
these critical knowledge gaps, we set out to profile chromatin landscapes of multipotency TFs in retinal
development using CUT&RUN. In Six3-occupied peaks, the most enriched de novo motif was often
neighbored by a Sox2-like motif, suggesting cooperative DNA binding between Six3 and Sox2. We
performed single-cell ATAC sequencing and found that Six3 and Six6 jointly regulate chromatin
accessibility. Additionally, we identified components in SIX3, SIX6, and SOX2 protein complexes isolated
from retinal progenitor cells. Subunits of BAF and/or PBAF complexes (mammalian SWI/SNF complexes),
KDMs, and HDACs were highly enriched in Six3 complexes and to a lesser extent in Six6 and Sox2
complexes. Additionally, SIX3 protein complexes contained variable amounts of PAX6, SOX2, and SIX6
proteins. The goal of this program is to elucidate molecular underpinnings of the multipotency and lineage
differentiation of retinal progenitor cells. We hypothesize that multipotency TFs Six3, Six6, Sox2, and Pax6
have both overlapping and distinct chromatin occupancies; these TFs cooperatively bind to cis-acting DNA
elements and then recruit chromatin remodeling proteins to regulate chromatin states in a context-
dependent manner for target regulation; their target genes collectively execute the control of the
multipotency and lineage differentiation of retinal progenitor cells. This hypothesis will be tested in two Aims.
Aim 1 is to elucidate how multipotency TFs of the retina regulate target genes in chromatin by assessing
chromatin occupancy, DNA-binding cooperativity, and chromatin remodeler recruitment. Aim 2 is to
determine how Six3, Six6, and Sox2 regulate chromatin accessibility at a cellular resolution. Elucidation of
the functions of multipotency TFs will provide pivotal insight into congenital eye abnormalities. Chromatin
occupancies of TFs, chromatin remodelers, and histone post-translational modifications in retinas will be
valuable resources for functional annotations of non-coding retinal disease SNPs in humans.

Public health relevance
Inherited retinal diseases cause a substantial burden for affected patients and our society. Accomplishments of the proposed studies will provide pivotal insight into the molecular mechanisms of inherited retinal diseases, including congenital eye abnormalities and retinal diseases associated with non- coding SNPs, facilitating therapeutic interventions.